The Role of Basa Bodies in Wnt Signaling

DESCRIPTION (provided by applicant): The ciliopathies are a group of >100 overlapping clinical disorders caused by defects in the primary cilium and its anchoring structure, the basal body. Although individually rare, this group contributes significantly to the population genetic disease burden. Fueled in part by genetic discoveries, the primary cilium is now appreciated to be a central component of paracrine signaling regulation, influencing our understanding of numerous developmental processes and disease mechanisms. During the previous funded period, we established the role of basal body proteins in regulating aspects of both canonical and non-canonical Wnt signaling. Using this information, we went on develop assays to probe the mechanistic basis of these observations and to study the effect of mutations found in ciliopathy patients. Our recent studies have also revealed a major, previously unappreciated, role of basal body proteins. We discovered that some basal body proteins regulate the selective proteasome-mediated degradation of signaling components and thus act as a homeostatic regulator of diverse signal transduction cascades. In this renewal, we propose three Aims. First, we will test the hypothesis that the observed proteasomal defects are driven, at least in part, by defective composition of the regulatory components of the proteasome and ask whether such defects are ligand-dependent or independent. Second, based on the hypothesis that proteasomal dysfunction contributes to the signaling phenotypes pathognomonic of ciliopathies, we will ask whether mutations in the 64 proteasomal subunits found in the ciliary proteome can contribute causal or modifying alleles to patients with diverse ciliopathy phenotypes. Finally, our preliminary data have indicated that chemical agonists of the proteasome can ameliorate signaling phenotypes in both cells and live zebrafish embryos, raising the possibility that they might have therapeutic benefit. Therefore, we will investigate the ability of such agonists to attenuate or ameliorate ciliopathy phenotypes in a mouse model. Taken together, our studies will inform the fundamental mechanisms that underpin ciliopathies, potentially providing an orthogonal view of the functions of this organelle, and will provide potential insights that can lay the foundation for clinical trials in humans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Establishing a role for the basal body in regulating proteasome-dependent degradation will have major consequences on a) understanding of the mechanisms of ciliopathies and b) identifying new causal and modifying loci and alleles. Finally, success in our mouse drug trials will contribute to the development of drug trials in humans. __SpecificAimsTextDelimiter__ Specific Aims The ciliopathies are a diverse group of human genetic disorders that have garnered significant interest in recent years. However, despite the identification of pathogenic mutations in >50 genes, the mechanisms by which ciliary mutations contribute to disease causality and variability are poorly understood. We and others have shown previously that loss of some basal body proteins leads to defects in the balance between canonical and non-canonical Wnt signaling, which, together with a host of other studies, has contributed to the idea that the primary cilium and basal body are hubs for a range of paracrine signaling that prominently includes Shh and Notch. These observations have enabled us and others to develop in vivo assays for the evaluation of candidate pathogenic mutations in patients; this has facilitated the identification of a host of ciliopathy genes and has informed disease architecture. During the first funding period, we showed that BBS4, a basal body protein that causes Bardet-Biedl syndrome, interacts with the proteasome regulatory subunit 10 (Rpn10) and that this interaction is likely relevant to some signaling phenotypes, since loss of RPN10 can phenocopy BBS-driven Wnt defects. Further, computational analyses of the Ciliary Proteome Database showed a striking enrichment for proteasomal proteins, probably reflective of the known aggregation of proteasomes around the pericentriolar region. Taken together, these observations led us to hypothesize that the basal body has a role in proteasome-mediated degradation. Consistent with this idea, we have now shown that ablation of basal body genes causes the accumulation of signaling components (Wnt, Shh, Notch, NF-κB) in a proteasome-dependent manner and that, remarkably, we can rescue these signaling defects by activating the proteasome in vitro and in vivo. Finally, our Preliminary Data have also suggested that some basal body proteins are necessary for the targeting of regulatory subunits to the pericentriolar fraction of the proteasome. Based on these observations we hypothesize that: 1) the centrosomal proteasome is organized dynamically by basal body proteins that might be signal-dependent and cilium-dependent; 2) the proteasomal subunits in the ciliary proteome represent a major target for causal and modifying mutations in ciliopathy patients; and 3) augmentation of proteasomal degradation might be of therapeutic benefit. We propose three specific aims: Aim 1: Identify proteasome subunits whose composition is basal body and ciliary dependent. We hypothesize that the basal body plays a role in controlling proteasome composition that is akin to the reorganization of the proteasome regulatory component under conditions of stress. To test this, we will suppress two basal body (BBS4, OFD1) or two axonemal (IFT88, IFT139) genes in hTert-RPE1 cells stably expressing tagged proteasomes, expose cells to ligand (Wnt3A conditioned media or SAG), and evaluate proteasomal composition through a combination of co-immunoprecipitation and sedimentation studies. Aim 2: Sequence proteasome subunits to determine their contribution to total mutational load in ciliopathies. We have identified 64 proteasomal regulatory subunits in the ciliary proteome. We will take advantage of a) the availability of >500 ciliopathy families with broad spectrum of phenotypes; and b) the availability of next-gen sequencing tools and expertise in our lab to sequence these genes in our cohort. Subsequent to sequencing, we will functionally evaluate all alleles using our established medium-throughput zebrafish complementation assays. Once the effect of alleles is determined, we will ask whether variation in this biological module contributes causal and/or modifying alleles. Aim 3: Develop therapeutic paradigms for ciliopathies. Our Preliminary Data have suggested that Sulforaphane (SFN), a known proteasome agonist, can ameliorate the Wnt, Notch, Shh and NfκB signaling phenotypes of basal body mutants and suppressants in vitro and in vivo. This compound is safe (FDA approved) and has also been used, with some benefit, in rodent models of photoreceptor degeneration1 and nephropathy2. We will therefore ask whether systemic treatment of mice ablated for Bbs4 can attenuate some of the ciliopathy phenotypes of the animals, with a focus on defects that are a) found broadly in ciliopathies; b) are thought to be driven by signaling defects; and c) can be assayed quantitatively. Specifically, we will monitor the effect of SFN on renal cyst formation and the rate of retinal degeneration. Completion of our studies offers the opportunity to fundamentally improve our understanding of the basal body and its composition and to outline a unifying hypothesis that can explain the broad incidence of paracrine signaling defects in ciliopathies. This in turn can impact our understanding of the disease in patients and provide the first opportunity to develop therapeutic paradigms that can be lead to clinical trials.